The function of germ granule processes that maintain pluripotency in the C. elegans germline

Project Summary
The pluripotent potential of a cell is generally assumed to be a product of its nucleus, regulated by gene
expression and chromatin state. This view informs most approaches to drug discovery, where an ideal
therapeutic would target nuclear processes to induce pluripotency and proliferation to heal a wound or inhibit
pluripotency and proliferation in cancer. Often overlooked are somatic cell nuclear transfer experiments that
definitively show cellular potential is also a product of the cytoplasm, specifically, the cytoplasm of germ cells.
The long-term objectives of this research are to understand how cellular pluripotency and regenerative capacity
are retained in germ cells through their specialized cytoplasm. We expect these findings to inform and expand
approaches to drug discovery and lead to therapeutics that function by targeting the cytoplasmic milieu.
Cytoplasmic processes unique to germ cells often occur in protein/RNA assemblies that reside on or near
the nuclear periphery. These assemblies are collectively called germ granules. Because core germ-granule
composition is conserved from nematodes to humans, we can use C. elegans nematodes to visualize germ
granules in vivo and to expedite studies into their function. Mutations that displace or severely disrupt germ
granules in C. elegans cause sterility and germline-to-somatic reprogramming. In this proposal, we look at the
earliest events of somatic reprogramming to determine how processes within germ granules antagonize this fate.
We investigate the contribution of glycine-rich repeat motifs to the specialized germ-granule microenvironment.
We then describe two novel interactions with a core germ-granule protein called GLH-1 (DDX4 in humans). One
of these interactions with GLH-1 likely facilitates the hand-off of mRNAs from germ granules to initiate translation.
The other is a dynamic interaction with GLH-1 that activates a conserved cellular pathway to trigger engulfment
by surrounding soma. Lastly, we follow up on another core germ-granule protein that we named LOTR-1
(TDRD5/7 in humans) and its LOTUS-domain-dependent interaction with a 3’UTR binding complex. Together,
these findings will provide an understanding of cytoplasmic processes within germ granules that ensure the
pluripotent potential of germ cells.

Public health relevance
Project Narrative Cellular pluripotency in the germline is maintained through processes within cytoplasmic assemblies called germ granules. Core germ-granule proteins are conserved in almost all animals, frequently repurposed during development, and re-expressed in multi-potent cancers. Understanding the function of individual germ-granule proteins, the purpose and conditions of their assembly, and their capacity for cellular reprogramming, will lead to applications that improve reproductive health, regeneration, and cancer therapeutics.